TASTE QUALITY ALTERATION

Subjects will participate in: psychophysical studies of taste and smell preception, questionnaires to assess food preference and annual food intake, measured weight and height, and preference rating of sample foods.